Long-term effects of universal health insurance in developing countries: Evidence from Mexico

Project Title
Long-term effects of universal health insurance in developing countries:
Evidence from Mexico
Project Summary/Abstract (30 lines of text)
The implementation of government programs to increase access to health insurance has rapidly increased in
developing countries in the last three decades. However, evidence on their long-term effects in a developing
country is limited and provides mixed conclusions. Understanding the persistent impact of universal health
insurance is particularly relevant as the hypothetical health improvements and reduced financial burden they
may offer have the potential to shrink intergenerational transmission of poverty and improve social mobility of
beneficiaries and their children. The efficacy of these programs remains unclear predominantly because of a
lack of random variation in their implementation and the fact that in randomized controlled trials, control
groups typically receive the benefits, at most, only a few years after the initial implementation. Long-term
evaluation of these programs is further complicated by the substantial challenges of consistently tracking
and following up baseline respondents, which can lead to bias-inducing, non-random attrition. This project
contributes to filling the gap in what is understood about the broad consequences of increased access to
health insurance in developing countries. Specifically, we provide new evidence from a population-
representative sample on the long-term effects of Seguro Popular, a universal public health insurance
program introduced in Mexico in 2002. Pairing the richness and innovative design of the Mexican Family Life
Survey (MxFLS), a nationally representative, longitudinal survey with cutting-edge and rigorous non-
experimental methods, represents a unique opportunity to make a substantial contribution to understanding
the persistent impact of programs that increase access to health insurance in developing countries. The
MxFLS collects comprehensive respondent data across time whereby every respondent surveyed in Mexico
at baseline in 2002, and any of their children born after 2002, are target respondents for follow-up survey
waves, including those who are domestic or international migrants. By integrating the MxFLS's ability to track
economic and health outcomes of respondents over multiple years with the temporal and spatial variation
created by Seguro Popular's rollout, as well as, the biological variation generated by the age individuals are
first exposed to the program, this project will: 1) identify the causal effects of Seguro Popular on child height,
which has been causally associated with indicators of well-being in later life, e.g., educational attainment,
earnings, adult health, and mortality; 2) explore the dynamic impact across time of this health insurance
policy to provide new insights into how supply and demand side constraints at the time of program
implementation can alter its effectiveness; and 3) provide evidence on the impact of Seguro Popular on
household expenditure, labor market, investment, risk, and migration behavior. In so doing, the project will
have provided scientific evidence on the extent to which the provision of health insurance in a developing
country setting improves the lifelong health and wellbeing of its population.

Public health relevance
Project Narrative (3 sentences) Public health insurance programs are being implemented across the globe, putting substantial pressure on public finances, despite the fact that there is limited evidence on their causal impact in the long term. This study will address this knowledge gap by utilizing the rollout of Seguro Popular, a nationwide program that provides public health insurance to approximately half of Mexico’s population. By exploiting the panel nature of the Mexican Family Life Survey, the first large-scale, nationally representative survey that has successfully followed respondents across international borders, this project will merge detailed migration histories, rich individual and household health and economic survey questions, and program rollout information to identify and document the extent to which providing universal health insurance in a developing country can improve fetal development, support child health, promote wellness over the life course, and ultimately, reduce existing economic disparities through improved household finances, nutrition, and provision of public health resources.